NALMEFENE REVERSAL OF SYSTEMIC EFFECTS OF INTRATHECAL MORPHINE

The purpose is to compare the ability of the drugs nalmefene vs. naloxone to reverse respiratory depression after an intrathecal dose of morphine.